CD spectropolarimeter

Project Summary
The objective of this proposal is to request a circular dichroism (CD) spectropolarimeter to enhance the
biomedical research and education capabilities at UMass Dartmouth and in Southern Massachusetts. The
requested instrument is a JASCO CD spectropolarimeter that covers a broad spectral range (163-1600 nm)
and comes with accessories, including a temperature control stage, micro-sampling, titration system, and a
solid-state measurement unit. Biological molecules are chiral, and their structures play a crucial role in
regulating cellular functions and impacting human diseases. The CD spectropolarimeter is a valuable tool for
characterizing these structures. The requested instrument will be used to investigate the structures of chiral
nanoparticles and biomolecules, thereby supporting ongoing research and educational programs in the
biomedical fields at UMass Dartmouth. These efforts align with the university's long-term goal of advancing
biomedical research and developing therapeutic methods for the treatment of human diseases.
We urgently require this instrument as it will be the only CD spectropolarimeter at UMass Dartmouth and in
Southern Massachusetts. Currently, faculty members who rely on the CD spectropolarimeter in their research
send samples to an external company and pay a usage fee of $100 per sample. The absence of this
instrument hampers the progress of biomedical research and impedes the development of educational
programs at UMass Dartmouth. The CD spectropolarimeter not only supports the research efforts of major
users but also promotes collaborations among faculty members in the Departments of Chemistry and
Biochemistry, Biology, and Bioengineering. Furthermore, several undergraduate and graduate lab courses will
benefit from this instrument by incorporating new labs, as the CD spectropolarimeter is currently inaccessible
to users on our campus. Moreover, if funded, it will provide research and education opportunities for local
universities and community colleges in Southern Massachusetts, as it will be the only CD spectropolarimeter
available in this region. Broad access to this instrument is expected, with users from UMass Dartmouth, local
academic institutes, and industry partners. We anticipate significant benefits from this NIH instrument grant.

Public health relevance
Project Narrative This project aims to request funding to purchase a JASCO CD spectropolarimeter with adequate accessories to investigate the structural information of biological molecules. This instrument, currently unavailable to UMass Dartmouth, will promote the University's biomedical research and education capabilities. Broad access to this spectropolarimeter is expected with users from UMass Dartmouth, local academic institutes, and industry partners.